HSR&D Research Career Scientist Award

Dr. Chinman is an accomplished researcher who has made pioneering theoretical, methodological, and
empirical contributions to implementation science and to the deployment of VA Peer Specialists—Veterans
with serious mental illness, or SMI, who are trained and then employed by VA to help other Veterans with SMI
(~1200 are employed VA-wide). Funded by VA HSR&D, RR&D, and QUERI, his current VA portfolio focuses
on teaching Veterans with SMI cognitive and social skills and coaching Veterans with SMI who are obese to
lose weight—both featuring Peer Specialists as the primary interventionist. Dr. Chinman is also leading an
effort to develop and pilot a Peer Specialist-based suicide prevention program. In addition to Peer Specialists,
Dr. Chinman has been centrally involved in the development of implementation science since its inception,
designing and working on implementation trials in mental health, primary care, and after school settings. In
these trials, he has applied, evaluated, and refined Getting To Outcomes® (GTO®), a robust implementation
strategy with demonstrated effectiveness, and developed multiple frameworks to aid implementation
researchers. Dr. Chinman provides extensive mentoring at multiple levels, locally in Pittsburgh and nationally,
on Peer Specialist and implementation research—for example helping seven junior investigators secure
HSR&D CDAs. Lastly, Dr. Chinman has a track record of extensive collaborations with other investigators and
VA operations partners. For example, Dr. Chinman has been assisting the VA's National Director of Peer
Support since the inception of that position, to better understand Peer Specialist contributions and overcome
implementation barriers.
The goal for this Research Career Scientist (RCS) application is to provide support for an established
investigator to expand his current lines of research on Peer Specialists and to advance rigorous methods that
benefit implementation science. The outcome of this RCS proposal would be to improve Veterans' with SMI
access to care and VHA's capacity to deliver evidence based mental health practices through mentoring,
leadership, research, and implementation. The proposed award would help Dr. Chinman expand the breadth
and depth of his portfolio of theoretical and applied research on Peer Specialists (e.g., clarifying theoretical
mechanisms), further develop his implementation science contributions (including new tools and their
dissemination) and increase his mentoring in peer support and implementation science locally and VA-wide.

Public health relevance
This research career award focuses on helping Veterans with mental illness and developing methods to improve the VA's use of evidence-based practices—called implementation science. One type of mental health provider in VA are Peer Specialists—Veterans with serious mental illness trained to help other Veterans with mental illness. About 1200 are employed VA-wide, and the current and planned research portfolio includes a focus on understanding Peer Specialists' impacts and helping them overcome implementation challenges. In fact, many evidence-based mental health treatments do not make their way to Veterans and the other focus in this portfolio would be to use implementation science to reverse that trend. In addition to research, the career award enables continuing service to VA as well as mentoring and training early-stage and established investigators in designing, conducting, and disseminating high impact research that will result in improved quality of care for Veterans.